Maximizing and predicting sentence processing treatment outcomes in aphasia

Abstract Agrammatic aphasia (agrammatism), an acquired language disorder, affects the ability to produce and comprehend sentences and significantly impacts the ability to communicate. The choice of the most efficacious and cost-effective treatment for specific language impairments (including agrammatism) is a major challenge for clinicians, as is the ability to formulate prognostic statements about the effects of treatment, based on individuals' language and neural profiles. Advances in understanding the effects of treatment for sentence processing deficits are therefore important for providing optimal intervention. The present proposal builds on previous work showing that Treatment of Underlying Forms (TUF, [1-2]), a metalinguistic approach focused explicitly on improving sentence processing abilities in agrammatic aphasia, results in strong acquisition and generalization effects (see [1], for review), changes in on-line sentence processing as identified in visual world eyetracking studies [3-6], and adaptive neuroplasticity as measured by shifts in BOLD signal derived from functional neuroimaging [7-8]. The overarching goal of the proposed studies is to refine TUF to maximize its efficacy and boost treatment outcomes to ultimately increase its clinical use. We propose a set of studies that test the effects of early treatment components of TUF to identify those that are most critical for successful outcomes (Aim 1, Study 1), compare the relative effects of TUF and Verb Network Strengthening Treatment (VNeST) on offline, online and neural processing (Aim 2, Study 2), and examine the effects of noninvasive neurostimulation (i.e., high-definition, transcranial direct current stimulation (HD- tDCS)) as an adjunct to TUF (Aim 3, Study 3). In addition, we will use multimodal neuroimaging and behavioral data to examine the factors underlying successful treatment outcomes and develop algorithms for predicting responsiveness to treatment based on these variables (Aim 4, Study 4).

Public health relevance
Narrative Aphasia has a greater negative impact on quality of life than major diseases, including cancer and Alzheimer's disease. This project is significant in that it aims to refine Treatment of Underlying Forms [1-2], a well-studied treatment for sentence deficits in individuals with agrammatic aphasia, by identifying components of the treatment that are essential for successful treatment outcome, comparing its relative efficacy to another well-researched treatment for verb and sentence deficits in aphasia (VNeST [9]), evaluating the additive effect of neurostimulation, and identifying neural/ behavioral predictors of treatment outcome. The project's ultimate goal is to maximize treatment efficacy and aide clinicians in selection and implementation of treatment approaches.